CANNABINOID RECEPTORS IN NEURONAL CELLS AND BRAIN

The goal of this research is to characterize signal transduction mechanisms of the CB1 cannabinoid receptor. The specific aims are to test the following hypotheses: 1. Regulation of specific effectors by CB1 cannabinoid receptors is dependent upon specific G-protein subtype proteins in the N18TG2 neuronal model. 2. The HelixII-asp-Helix VII-asn interaction maintains a conformational constraint on the CB1 receptor that can be modified by Na+, leading to effects on signal transduction that differ with agonist class and G-protein type. The Helix VII-pro distal to the asn can transmit conformational changes important for signal transduction. 3. The HelixVII juxtamembrane C-terminal region regulates interaction with G-proteins, and this regulation is under the influence of structural modifications imposed by palmitoylation/depalmitoylation. 4. Phosphorylations of thr/ser on the CB1 receptor are regulatory mechanisms in CB1 receptor signal transduction. 5. Tyr phosphorylation is a post-translational modification that is a regulatory mechanism for CB1 cannabinoid receptor signal transduction, with particular emphasis on the NPIIY motif in HelixVII. These studies will provide a cohesive analysis of CB1 receptor conformational changes that are necessary to transmit the activating signal to specific G-proteins that mediate various neuronal responses. The emphasis for these studies is the proposed Helix II-Helix VII interaction that is hypothesized to trigger conformational control over the HelixVII juxtamembrane region which activates G-proteins. Specificity for G-proteins and modulation by post-translational modifications are proposed to be key regulatory mechanisms that govern the signal transduction capabilities of the CB1 cannabinoid receptor.